Protecting the Confidentiality of Participants in Studies of Alzheimer's Disease and Related Dementias by Replacing Face Imagery in MRI

PROJECT SUMMARY / ABSTRACT
There exists a growing demand to share all publicly-funded research data, including magnetic resonance
images (MRI). Concurrently, it has been shown that high-resolution facial reconstructions can be generated
from MRI, and face recognition software can match these reconstructions with participant photos. Standard
MRI de-identification removes participant names from the image header, but does nothing to prevent face
recognition. Identified individual research participants would be irreversibly linked with all the collected
protected health information, such as diagnoses, biomarker results, genetic risk factors, and neuropsychiatric
testing. Although data use agreements can legally protect study administrators, these legal mechanisms do not
directly protect participants. If participants were publicly identified by a careless or malicious individual, this
event would significantly and permanently erode public trust and participation in medical research. Many large
imaging studies of Alzheimer's Disease (AD) and related dementias are vulnerable to this threat.
To address this threat, we propose a novel technique that de-identifies MRI by replacing facial imagery with a
generic, average face (i.e., a digital face “transplant”). Unlike existing methods that remove or blur faces, our
approach minimizes added bias and noise in imaging biomarker measurements by producing a de-identified
MRI that resembles a natural image. This imminent privacy threat grows with burgeoning technology and with
the increased public sharing of research data. We propose to: improve our de-identification software by
collaborating with a top expert in face recognition; further reduce effects on brain measurements; large-scale
test/validate on Mayo Clinic aging studies; add capability for de-facing additional imaging modalities; test and
improve performance when applied to diverse populations; and share the software freely for research use.
Aim 1: Refine and validate an optimized face de-identification algorithm: 1A) Further improve de-
identification performance; 1B) Further reduce impacts on brain biomarker measurements; 1C) Test and
validate using images from the Mayo Clinic Study of Aging and Alzheimer's Disease Research Center studies.
Aim 2: Add capability for de-identifying additional imaging sequences and modalities: 2A) Support
additional MRI sequences; 2B) Support PET images; 2C) Support CT images.
Aim 3: Investigate effects of age, race, and sex: 3A) Evaluate the effects of age, race, and sex on the
proposed de-identification method; 3B) Adapt software to ensure that the algorithm protects all participants
equally.
Aim 4: Disseminate software and educational materials: 4A) Share the software freely for research use; 4B)
Develop and disseminate materials and recommendations for research studies for protection of participant
privacy.

Public health relevance
PROJECT NARRATIVE Recent advances in magnetic resonance imaging and facial recognition technologies have together made it possible to create realistic images of participant faces from medical research images and automatically match these with photographs on a large scale, creating an imminent and growing threat to the privacy of research participants, including those in many large imaging studies of Alzheimer's Disease (AD) and related dementias. We propose a novel technique that de-identifies MRI by replacing facial imagery with an average face, producing a de-identified MRI that resembles an unmodified image and has reduced negative effects upon popular brain biomarker measurement software. We propose to develop/refine, extend, validate, and publicly share our technique to protect the privacy of research participants and promote wider, safer sharing of research imaging data.